National Antimicrobial Resistance Monitoring System using Retail Meat for Louisiana

NARMS Cooperative Agreement Program to Enhance and Strengthen Antibiotic
Resistance Surveillance in Retail Food Specimens
Agency Funding Opportunity Number: PAR-25-014
Louisiana
9/1/2025-8/31/2026
Abstract
This project supports the successful collection, processing, and testing of 23 retail meat
and seafood samples per month. Three staff from ID Epi and the Lab will ensure the
timely and accurate identification, collection, processing and submission of all samples,
in alignment with FDA and NARMS timelines.
Enhanced antimicrobial resistance (AMR) data specific to Louisiana will be analyzed to
identify trends, detect emerging threats, and inform agency decision-making and public
communication. These data will also support the development of evidence-based policies
aimed at AMR mitigation and prevention, reinforcing the critical role of the state health
department in protecting and improving the health of the public.
Planned enhancements include incorporating additional target organisms and
optimizing laboratory methods, including the expansion of whole genome sequencing
(WGS) to encompass these newly included organisms. These improvements will produce
higher-resolution data and strengthen the capacity to detect related cases or outbreaks
retrospectively, in real time, and prospectively. This work will strengthen coordination
with the FDA and other partners during outbreak investigations and ensure that
Louisiana contributes robust, actionable surveillance data to the national NARMS
program. Collectively, these activities will support efforts to shape national policy on
antimicrobial use and resistance.

Public health relevance
NARMS Cooperative Agreement Program to Enhance and Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens Agency Funding Opportunity Number: PAR-25-014 Louisiana 9/1/2025-8/31/2026 Narrative The retail meat program monitors trends in antibiotic resistance in retail meat items and other items, as may be requested by FDA. Activities include testing and whole genome sequencing for antibiotic resistance in Salmonella, Campylobacter, Enterococcus, Vibrio, and Aeromonas isolated from meat items purchased at retail food stores per FDA protocol.